Transgenic & Knock-out Mouse

Summary
It is clear that the progress of diabetes research during the coming decades will depend heavily upon the ability
to utilize the mouse as an experimental model to investigate both basic and clinically relevant questions in
diabetes research. The strong conservation between the genomes of humans and mice makes the approach of
using genetic alteration mouse technology to create models for human diabetes, endocrine pathologies, and
diabetes complications extremely useful. The Transgenic and Knock-out Mouse Core (TKMC) provides
investigators at UCLA and UCSD with a wide array of genetic manipulations in the mouse including targeted
deletions, insertions, and mutations using CRISPR/Cas9, transgenic genes, homologous recombination in
embryonic stem cells (ES cells), creation of chimeric mice from ES cells, and the most cutting-edge
approaches to performing reverse genetics in the mouse. Transgenic, knock-out, and CRISPR mouse models
are created that utilize the most advanced approaches including conditional Tet-inducible and tamoxifen-
inducible transgenes, tissue-specific and conditional knock-outs using Cre-LoxP and Flp recombinases and
recombination–mediated cassette exchange (RMCE), BAC transgenics, BAC-Trap, RiboTag, and other
specialized technologies. This long-standing Core is an outstanding example of how extraordinarily specialized
techniques, highly trained dedicated personnel, specially constructed facilities, and expensive equipment can
be accessed by researchers who could not reasonably expect to develop them on an individual basis.
Key objectives are:
1. To create innovative and important mouse models for studies of diabetes and its complications.
2. To eliminate barriers to the most cutting-edge mouse genetic approaches for the DRC membership.
3. To provide outstanding, reliable, and high quality mouse embryology and genetic services.
4. To advance the technology of genetic manipulation of the mouse genome.
The availability of this Transgenic and Knock-out Mouse Core in coordination with the other DRC Cores, will
continue to enable our members to conduct versatile, cutting-edge, reverse genetic research in the mouse with
a battery of multidisciplinary, state-of-the-art techniques.